Targeting skeletal muscle to improve exercise capacity in heart failure with preserved ejection fraction.

PROJECT SUMMARY
Heart failure with preserved ejection fraction (HFpEF) is the fastest growing form of heart failure, is almost
exclusively found in older persons and is associated with a high morbidity and mortality rate. The primary
chronic symptom in HFpEF patients is severe exercise intolerance measured objectively as decreased peak
exercise oxygen uptake (peak VO2). By convention, the majority of work to date has focused on central
limitations, however drug therapies targeting cardiac function do not improve peak VO2 or survival in HFpEF.
Emerging evidence from our group suggests that peripheral `non-cardiac' factors (e.g. decreased lean mass,
impaired oxidative capacity and muscle blood flow) contribute significantly to the reduced peak VO2 in HFpEF.
Exercise training is the only proven therapy to increase peak VO2 in older HFpEF patients, however the
peripheral mechanisms (skeletal muscle O2 delivery/extraction, oxidative capacity) responsible for this
improvement are unknown. A limitation of prior exercise training studies was the primary focus on whole body
exercise which in the setting of marked increases in cardiac filling pressures and impaired cardiac output
reserve—as occurs in HFpEF—may not be an optimal form of training for these patients. Exercise training
modalities focused on removing the central limitation to exercise (as occurs with dynamic single-leg knee
extension [KE] exercise) may prove more effective. Accordingly, the current project is dedicated to defining: a)
the specific “peripheral mechanism(s)” contributing to exercise intolerance in HFpEF, and b) specific
“peripheral” adaptations to exercise training. To achieve this objective, we will perform the first ever-direct
≥
measure of leg VO2, leg O2 (convective and diffusive) transport and extraction, using invasive intravascular
measures and Dopper ultrasound, during maximal dynamic single-leg KE exercise in older ( 60 years) HFpEF
patients with a “primary central” phenotypye (Type A, n=40), “primary peripheral” phenotype (Type B,
n=40) and controls (n=20). Our program grant Imaging Core we will also perform the most comprehensive in
vivo assessment of skeletal muscle metabolism (1H and 31P NMR spectroscopy) at rest and in response to
dynamic exercise. After baseline testing, Type “A” and “B” HFpEF patients will be randomly assigned to two
different forms of training, each which are uniquely focused on removing the central limitation to exercise
(Group 1: dynamic single-leg KE exercise; or Group 2: sublingual nitroglycerin given prior to and during cycle
exercise training to lower cardiac filling pressures). Given the pathophysiology of exercise intolerance and
mechanisms for improvement with physical training is poorly understood, and no medications have been
proven effective, our results have the potential to shift paradigms, and have a major impact on the
management of older patients with HFpEF in a short-time period.

Public health relevance
Project Narrative: Heart failure with preserved ejection fraction (HFpEF) is the fastest growing form of heart failure with a high morbidity and mortality rate, and is associated with severe exercise intolerance, the hallmark symptom in older HFpEF patients. This proposed research will test a novel paradigm that peripheral skeletal muscle abnormalities contribute to exercise intolerance, and an important target of therapy to improve exercise capacity with physical training in older HFpEF patients. Given that no evidence-based therapies have been shown to improve clinical outcomes, the findings from the proposed research may have a major impact on the management of elderly HFpEF patients.